Omics and Exposures Facility Core

The Center for Integrated Environmental Health Sciences (CIEHS) goals are to understand how life
style factors interact with exposure to environmental toxicants in human health and disease, and to
enhance the capacity for environmental health research at the University of Louisville (UofL). UofL
shared resource facility cores offer cutting edge scientific services, enabling access to high-end
equipment, advanced techniques and specialized expertise that would typically be inaccessible for an
investigator. It is essential for the modern environmental health scientist to understand the numerous
available shared resource facility cores; in terms of accessibility, effective experimental design, dataacquisition
and -analyses. The Integrated Toxicomics and Environmental Measurement Facility Core
(ITEMFC) will create a central resource for CIEHS members, allowing them to understand, access and
effectively use environmental ‘omics resources. The ITEMFC will coordinate activities between CIEHS
members and the existing UofL shared resource facility cores. The ITEMFC will be comprised of six
discrete technology-centric components: genomics/ transcriptomics, proteomics, metabolomics,
metallomics, metagenomics, and controlled inhalation exposure studies. The ITEMFC will focus its
efforts on advising investigators on study design, facilitating shared resource facility cores use, and
educating Center members and trainees on these technologies. Additionally, the ITEMFC will facilitate
the transfer of ‘omics data to the Biostatistics and Informatics Facility Core (BIFC). It will accomplish
these goals through the following specific aims: Aim 1. Increase access and facilitate use of UofL
shared resource facility cores. ITEMFC will serve our members by (a) explaining the various cores and
how they operate, (b) establishing direct interactions with the right shared resource director to select
the appropriate technology. We will aid in experimental design and closely collaborate with all Facility
Cores to streamline sample handling and data analysis. The ITEMFC will also supplement the cost of
member studies. Aim 2. Cultivate awareness, interest and understanding of the ITEMFC shared
resource facility cores. The ITEMFC will support CIEHS members by (a) drawing attention to the
shared resource facility cores, (b) suggesting how the ITEMFC may enhance their approach in
answering their research questions, and (c) support educating the next generation of environmental
scientists in the various technologies. Aim 3. Facilitate submission of CIEHS members’ grant
applications proposing to use ITEMFC Resources. The ITEMFC will support CIEHS members in their
grant applications that include ‘omics-based aims. The integrated services and expertise of the ITEMFC
are essential to achieve CIEHS goals and to make progress with regard to understanding the diverse
pathological consequences of exposure to environmental toxicants together with lifestyle factors.